Sequence determinants of membraneless organelle rheology -- Research supplement to promote diversity

PROJECT SUMMARY/ABSTRACT
This is an application for a Research Supplement to Promote Diversity in Health-Related Research to
complement our parent grant, “Sequence determinants of membraneless organelle rheology” (R35
GM142903). The supplement funds will support Bruna Favetta, who in Fall 2021 is starting her second year as
a Ph.D. student in the Department of Biomedical Engineering at Rutgers University. Bruna has excellent
background, motivation, and ability to contribute to the overall goals of the parent grant. The objective of the
parent grant is to understand how the sequences of intrinsically disordered proteins (IDPs) contribute to the
rheology of membraneless organelles (also known as biomolecular condensates), and ultimately how that
rheology relates to function. Bruna is Hispanic and is committed to serving as a role model for
underrepresented minorities in biomedical research, both at Rutgers and in her future research career. Bruna
has conducted research at several universities and institutions beginning when she was only in high school,
giving her a unique perspective on research in diverse settings around the globe. Bruna brings these
experiences to advance her own research at Rutgers and to enrich the overall scientific community through
fostering greater understanding of diversity in research. Together, we have crafted a plan for Bruna’s training
and research during her Ph.D. studies. Bruna will study the rheology of biomolecular condensates formed from
the IDPs of the SARS-CoV-2 virus. These proteins phase separate into biomolecular condensates during the
viral replication lifecycle, and we hypothesize that the rheology of these condensates has important functional
consequences for viral assembly, including membrane scission. The first goal is to quantify the rheology of the
multiphasic condensates composed of the nucleocapsid (N) and membrane (M) proteins of SARS-CoV-2.
Next, we will assess how perturbations to the rheology of these viral condensates may affect their biological
function, such as orchestrating the important processes of membrane bending and viral membrane scission.
Overall, this research will foster Bruna’s training and will advance our understanding of how IDP sequence
determines biomolecular condensate rheology and how this rheology gives rise to biological function, which is
the overarching focus of the parent R35 grant.

Public health relevance
PROJECT NARRATIVE This is a diversity supplement request for PA-21-071, under award 1R35GM142903-01 (PI: Schuster, Benjamin).